Purinergic Signaling in Fibroblast Activation and Lung Fibrosis

Project Summary/Abstract
Idiopathic pulmonary fibrosis (IPF) is a devastating and progressive lung disease characterized by extensive
fibrotic remodeling leading to respiratory failure and death. Despite recent advancements, no curative treatments
exist for IPF, underscoring the urgent need to identify novel therapeutic targets. Recent studies suggest a
potential role for purinergic signaling in IPF pathogenesis, particularly through the actions of extracellular ATP
(eATP): Elevated eATP levels have been observed in the bronchoalveolar lavage fluid of IPF patients, implicating
this signaling molecule as a potential driver of disease progression. However, the functional impact of eATP in
the context of lung fibrosis remains poorly understood. Addressing this knowledge gap, our research has
identified the fibroblast-specific ATP receptor P2rx4 as a key mediator of fibrotic signaling. Deletion of P2rx4 in
fibroblasts has been shown to reduce lung fibrosis in bleomycin-treated mice, making it a promising target for
therapeutic intervention. Notably, P2rx4 is highly expressed in pathologic fibroblasts in both human and mouse
models of lung fibrosis, reinforcing its relevance in the fibrotic process. Our preliminary data suggest that the
eATP-P2rx4 signaling axis regulates several profibrotic fibroblast phenotypes, including the upregulation of
collagen genes, production of the cytokine IL-6, and enhanced fibroblast proliferation. This proposal seeks to
dissect the underlying mechanisms by which P2rx4 influences these fibrotic pathways in fibroblasts. In Aim 1,
we will test the hypothesis that the eATP-P2rx4-p38 MAP kinase signaling pathway is a critical regulator of
fibroblast activation and the emergence of pathologic fibroblasts. We will also investigate the role of mitochondrial
reactive oxygen species (mitoROS) in mediating P2rx4-dependent p38 MAP kinase activation. Aim 2 will focus
on evaluating the therapeutic potential of targeting P2rx4. P2rx4 inhibition will be tested in both translationally
relevant mouse models of lung fibrosis and in precision-cut lung slices derived from IPF patient explants to
assess efficacy in reducing collagen deposition and fibrosis. Aim 2 will also test the relevance of the profibrotic
eATP-P2rx4-p38 signaling that our preliminary data indicate for mouse in primary human lung fibroblasts from
healthy donor and IPF lung explants, by siRNA knockdown of P2rx4 and p38. Taken together, these studies will
transform understanding of purinergic signaling in lung fibrosis, providing critical insights into the molecular
mechanisms that drive fibroblast activation IPF. By identifying and validating ATP-P2rx4 signaling as a novel
therapeutic target, this research has the potential to pave the way for the development of new and effective
treatments for IPF.

Public health relevance
Project Narrative A hallmark of lung fibrosis is the activation of fibroblasts, which are responsible for the majority of collagen deposition and contribute to lung remodeling. The current research seeks to understand how extracellular ATP signaling induces pathologic collagen expression by fibroblasts. The goal is to advance understanding of the pathophysiology of lung fibrosis and to derive novel therapies for fibrotic lung diseases, including idiopathic pulmonary fibrosis.